MR^3: Development of a Molecular Rotational Resonance Ratiometer

MR3: Development of a Molecular Rotational Resonance Ratiometer
NIH SBIR Direct to Phase II
BrightSpec, Inc.
Project Summary
This project proposes the development of a molecular rotational resonance (MRR)
ratiometer for precisely quantifying the relative abundances of components of complex
mixtures, such as trace isotopologues in natural abundance, major and minor enantiomers
in chiral mixtures, and a variety of components in reaction aliquots (starting materials,
intended products and side products, etc.). MRR is a spectroscopic technique for
unambiguous structure determination and quantitation of small molecules, which has
been used for decades in academic research laboratories but only recently
commercialized by BrightSpec, driven by recent groundbreaking innovations. The key
advantages of MRR are its selectivity to isomeric compounds (including isotopomers in
natural abundance), absolute quantitation capabilities, and identiﬁcation of unknowns
without reference standards. By further developing the technique to use multiple
microwave ﬁelds to simultaneously probe the same sample volume, measurement
variability can be substantially reduced, opening new horizons in a broad array of research
areas including drug discovery, natural products analysis, and the monitoring of
environmental pollutants.
A proof-of-concept dual axis spectrometer has been used to demonstrate the viability of
measuring molecular data in two diƯerent frequency ranges, and we also have data
showing the viability of wire-grid polarizers to allow for simultaneous monitoring of two
molecular transitions in spatially overlapped microwave cavities at once. Overcoming
these major technical challenges has de-risked this proposed Phase II project, and
remaining work will focus on optimizing instrument performance and reducing
measurement variability on both short and long timescales. The product will then be tested
thoroughly on relevant samples in market areas where the MRR ratiometer is expected to
have the greatest impact. Once these new measurement capabilities are integrated into
our instrument control software, the product design will be reﬁned for commercial launch
at or before the end of the grant period.

Public health relevance
MR3: Development of a Molecular Rotational Resonance Ratiometer NIH SBIR Direct to Phase II BrightSpec, Inc. Project Narrative Complex chemical mixtures are ever-present in real-world science, and their accurate analysis and quantiﬁcation is at the heart of pharmaceutical research, where molecules are precisely assembled step-by-step and impurities or unwanted side products can have deleterious eƯects on human health. The proposed project will signiﬁcantly enhance the ability of researchers to quantify the relative components of complex mixtures, down to trace levels, by using multiple microwave ﬁelds at diƯerent frequencies in a dual-axis Molecular Rotational Resonance (MRR) ratiometer to simultaneously probe an identical sample volume, greatly reducing measurement variability. The resulting commercial MRR ratiometer will have dramatically improved accuracy and reliability in quantifying complex mixtures, giving researchers much richer and deeper information about their samples and opening new research horizons.